A molecular toolbox to accelerate drug development for histone lysine methylation regulators

PROJECT SUMMARY
Nucleosomes (Nucs) are the repeating unit of chromatin structure and are decorated with diverse post-
translational modifications (PTMs) to regulate gene expression. The enzymes that add and remove lysine
methylation (KMTs & KDMs) on Nucs play driving roles in many diseases and are important targets for cancer
therapy. However, the complexity of chromatin structure has greatly challenged the accurate characterization of
these enzymes for drug development. Indeed, many KMTs & KDMs contain multiple domains that engage
distinct Nuc features in a multivalent manner, underscoring the need to use full-length enzymes and Nucs to
define their activity. Notably, these reagents are difficult / costly to produce, require extensive / customized assay
optimization, and are not widely supported by existing high-throughput screening (HTS) platforms, driving the
use of protein domains and non-physiological histone peptide-based assays. Further, the field has been stalled
by the lack of target-focused chemical compound sets, which are crucial to KMT & KDM inhibitor development,
mechanistic analysis, and drug design. Better tools are needed to support this key area of biomedical research.
Here, EpiCypher® is directly addressing these problems with the development of EpiVance™, a
comprehensive toolbox comprising dNuc substrates, full-length enzymes, validated assays, user-friendly
protocols, and a KMT & KDM focused chemical library to advance chromatin research. This innovative,
integrated system will enable reliable and sensitive characterization of diverse KMTs & KDMs, which will improve
our understanding of these enzymes for therapeutic development. For Phase I proof-of-concept, we developed
HTS-compatible enzyme assays for nine KMTs & KDMs using dNuc (or peptide) substrates. We then worked
with expert medicinal chemists Drs. Jian Jin and H. Ümit Kaniskan to apply an innovative structure-based
optimization strategy, expanding existing KMT & KDM inhibitors into a 200-compound set for HTS. We
discovered several compounds with novel target selectivity and found that a defined G9a inhibitor also displayed
potent activity towards KDM7A, illustrating the importance of rigorous counter-screening to related enzymes and
demonstrating strong feasibility for our approach. In Phase II, we are partnering with Cayman Chemical to
exclusively develop and commercialize the EpiVance toolbox and services for drug discovery research. In Aim
1, we will develop a series of HTS assays using full-length KMT & KDM enzymes, dNuc substrates, and highly
specific antibodies. In Aim 2, we will work with Drs. Jin / Kaniskan and Cayman Chemical to expand open-source
KMT & KDM inhibitors, generating an ~500 compound set. In Aim 3, we will complete end-to-end validation of
this system, performing HTS using select enzyme assays from Aim 1 and the chemical set from Aim 2. This
project will demonstrate the power of EpiVance for accurate enzyme characterization and inhibitor development,
thereby fulfilling a major need in the chromatin field. Our team’s expertise in assay development and medicinal
chemistry uniquely positions us to deliver this system, which is expected to have significant market impact.

Public health relevance
PROJECT NARRATIVE Histone lysine methyltransferases and demethylases (KMTs & KDMs) play important roles in regulating chromatin structure and gene expression, and are widely indicated in disease, making them key therapeutic targets. However, the study of KMTs & KDMs for drug development has been challenged by the lack of reliable, physiological enzyme assays and targeted chemical libraries – crucial to define enzyme activity and identify selective inhibitors. Here, EpiCypher® is developing EpiVance™, a comprehensive system that will accelerate drug discovery research for high value histone lysine methylation regulators that remain largely undruggable using current technologies.